Mechanisms of cardiomyocyte dysfunction in pediatric septic shock

PROJECT SUMMARY / ABSTRACT
Title: Mechanisms of cardiomyocyte dysfunction in pediatric septic shock
Despite decades of research in pediatric sepsis, mortality remains at approximately 25% for children with
septic shock. Sepsis-associated myocardial dysfunction (SAMD) is common in children and has an association
with mortality that is not simply a reflection of the severity of illness. As no disease-modifying therapies exist for
SAMD, there is a critical need to understand the biologic basis of cardiomyocyte dysfunction in sepsis.
Furthermore, there is a need for novel human modeling with patient-derived materials given the failure to
translate molecular discoveries in murine models of sepsis to improvements in human organ injury. Our
objectives are to establish human induced pluripotent stem cell (hiPSC)-derived cardiomyocytes (hiPSC-CMs)
as a model for cardiomyocyte dysfunction in pediatric sepsis and to examine the roles of host genetic
background and serum factors in the pathogenesis of SAMD. We have built upon our large, established
biobank of serum from children with sepsis to study the cardiomyocyte response to septic serum banked from
children who did and who did not have SAMD. We have found that the contractility of hiPSC-CMs is depressed
by serum banked from children with SAMD but not by control septic serum from children without SAMD. This
depressant effect was reversible after removal of the serum, suggesting this was not reflective of cell death.
Furthermore, we identified a significant association of interleukin-8 (IL-8) with SAMD in children with septic
shock and found that recombinant human IL-8 depresses hiPSC-CM contractility. Our proposal will address
three important questions as specific aims: First, we will determine whether hiPSC-CMs and cardiomyocytes
derived from the same children share common functional and transcriptional patterns of responses when
exposed to banked septic serum. We will provide a comprehensive comparison of hiPSC-CMs to ex vivo
cardiomyocytes by isolating cardiomyocytes from discarded surgical tissue from children undergoing cardiac
surgery and by generating hiPSC-CMs from these same patients. Second, we will determine the degree to
which host genetic background contributes to cardiomyocyte dysfunction in SAMD. We will develop hiPSC-
CMs from pediatric patients with and without SAMD to determine responses to septic serum to identify patterns
of functional and transcriptional responses associated with susceptibility to SAMD. Third, we will dissect the
role of IL-8 signaling in cardiomyocyte dysfunction in sepsis. We will employ a combination of IL-8 modulation
in serum and IL-8 receptor (CXCR1 and CXCR2) knockouts in hiPSC-CMs, providing evidence for IL-8
blockade as a potential therapeutic target in SAMD. This career development proposal will build on my
background in translational research in myocardial dysfunction to gain new expertise in cardiomyocyte
functional analysis, hiPSC generation and differentiation, and next-generation RNA sequencing technology to
facilitate my transition to independence as a physician-scientist focused on elucidating and targeting
mechanisms of pediatric SAMD.

Public health relevance
PROJECT NARRATIVE One in four children with septic shock die despite receiving intensive care and antibiotics, and cardiac dysfunction seems to contribute to this high mortality rate. No treatments exist for cardiac dysfunction in sepsis, and our goal is to better understand the causes of cardiac injury in children with septic shock to facilitate development of new medications to help these children recover and survive. We will study these processes using human cardiac cells and human serum, rather than animal models, to improve the ability to translate discoveries back to the bedside to improve patient care.